Zebrafish Biomedical Research Facility Core

PROJECT SUMMARY – Zebrafish Biomedical Research (ZBR) Facility
Core
The OSU Environmental Health Sciences Core Center (EHS CC), has developed a new, integrated approach to
address major elements of the NIEHS strategic plan. The environmental health sciences community is
becoming increasingly aware of the value that aquatic models can provide to identify chemical hazards and to
dissect the molecular pathways that influence disease. Over the last 10 years, with substantial EHS CC, NIEHS,
and Institutional investments, the Zebrafish Biomedical Research (ZBR) Facility Core has pioneered the
zebrafish model as an ideal vertebrate platform for discovery and translational research. The ZBR has created
one of the world's largest zebrafish toxicity facilities. We can assess responses to chemicals, nanoparticles, and
mixtures in over 3,000,000 animals annually. We operate the world's only certified specific pathogen-free
facility. We have developed innovative software and instrumentation that enable us to identify bioactive
compounds and to identify adverse outcome pathways. Our studies enable investigators to prioritize chemicals
for mammalian and epidemiological studies, and they provide a path toward biomarker and therapeutic
discovery. We operate the ZBR as a full-service facility for a dynamic cadre of EHS CC investigators and
stakeholders. Our central goal is to remove the technical and knowledge barriers so they can advance their
research programs by exploiting the unique advantages of zebrafish. The ZBR interfaces seamlessly with the
Chemical Exposure Core (CXC) and the Integrated Health Sciences Facility Core (IHSFC) and the Community
Engagement Core (CEC) to advance EHS research. The ZBR will specifically 1) help EHS CC investigators
understand the advantages and limitations of conducting environmental health sciences research with non-
human models; 2) provide technical core support and specific-pathogen-free zebrafish for short- and long-term
studies; 3) provide unprecedented high-throughput research platforms to evaluate toxicity and to determine
toxicity mechanisms.